Effectiveness and Implementation of a Meditation App addressing Substance Use, Sexual Health, and Emotion Regulation among Legal-Involved Youth

Young people are arrested at high rates in the U.S., particularly in minoritized communities, and face stark
behavioral health disparities related to substance use and sexual health compared with peers who have not
been arrested. Low emotion regulation appears to be a common mechanism underpinning these disparities and
it can be improved via mindfulness meditation. Moreover, meditation can be taught by smartphone app, holding
the potential to reach youth on probation—who make up the large majority of all young people in the legal
system—in their daily lives. In a prior NIDA-funded study (K99/R00DA047890), we collaborated closely with
youth and other stakeholders in Chicago Cook County, the 2nd largest juvenile legal system in the U.S., to identify
determinants of implementing a 1-month mindfulness meditation app with youth on probation, develop a package
of corresponding implementation strategies to promote app adherence (i.e., ongoing usage), and run a fully-
remote pilot RCT with n=70 youth on probation. The pilot data strongly supported feasibility and acceptability
including very high objective app adherence (mean=20.40 of 30 daily meditations, SD=7.99) and retention at 1
(86%) and 6 (80%) months. There were also multiple signals of greater reductions in substance use problems
and sexual risk behaviors among youth randomized to the meditation app than to a health promotion control app
matched for time and structure. Throughout the pilot RCT, youth and officers requested that the meditation app
be sustained in probation programming if it demonstrates effectiveness. This proposal is a response to our
stakeholders’ requests. The proposed study will proceed in 2 main steps corresponding to (1) testing the
effectiveness and individual-level implementation of the meditation app, and (2) starting to plan for its
sustainability on the organizational level. First, we will leverage our successful pilot RCT design to run a hybrid
type 2 effectiveness-implementation RCT with N=300 youth on probation in Cook County. Youth will be
randomized to use the meditation or health control app daily for 30 days. Objective usage data will identify non-
use of both apps and trigger adherence support (e.g., texts) via an adaptive intervention design. Youth will report
on the health outcomes (substance use and sexual health) and the mechanistic target (emotion regulation) at
baseline, 1, and 6 months. They will also complete 1-week “bursts” of ecological momentary assessment (EMA)
at baseline and 1 month to supplement the retrospective emotion regulation data with real-time, ecologically valid
reports. Together, this will allow us to test if the meditation app is effective in reducing substance use problems
and sexual risk (Aim 1a), if improvements in emotion regulation mediate these effects (Aim 1b), and if youth
adequately adhere to the app (Aim 2). To start systematically planning for sustainability of the meditation app in
probation programming (Aim 3), we will interview youth on probation, probation officers, and probation leadership
on organizational-level determinants of sustaining the app and implementation strategies for doing so. We will
then run a pilot sustainability trial with N=20 youth to test feasibility and acceptability of those strategies.

Public health relevance
Youth in the U.S. legal system experience stark behavioral health disparities related to substance use and sexual health compared with peers who have not been arrested, yet they are among those in the country who are least likely to receive effective health promotion services. Low emotion regulation appears to be a common mechanism underpinning these health disparities and it can be improved via mindfulness meditation. This study will leverage strong community partnerships, mobile health (mHealth) technology, and implementation science to test the effectiveness and implementation of a meditation app developed with and for youth on probation to address substance use, sexual health, and emotion regulation.